Step 1 in Designing Appropriate Shams and Controls in Human TUS

Project Abstract
The nucleus accumbens (NAc) is a target for non-invasive brain stimulation for the treatment of substance use
disorders (SUDs). Due to its location deep in the brain, transcranial ultrasound stimulation (TUS) is unique
among non-invasive brain stimulation methods to be able to focus on the NAc with high spatial resolution. TUS
has been shown to be safe and effective in animal models. It is currently under active investigation in humans.
However, a major concern in the use of TUS in human studies is the potential for an off-target auditory
stimulation by bone-conducted sound, making the study susceptible to placebo and attention effects, which are
relevant in most studies of neurological disorder interventions. The purpose of this proposed research is to
increase the rigor and safety, and therefore success, of TUS in the treatment of SUDs, and TUS more
generally, thereby enabling truly innovative science. We will do this by accurately quantitating the hearing
response from TUS waveforms in humans, including correlation to skull morphology, and designing and testing
a framework for creating waveforms that reduce audibility while improving masking, all while still providing the
flexibility needed by TUS researchers. We will do this for stimulation waveforms and for MR-ARFI waveforms,
which we show in preclinical data provide a measure of the dose-response to the ultrasound stimulation.

Public health relevance
Project Narrative Completely noninvasive neuromodulation using transcranial ultrasound stimulation (TUS) offers the promise of precisely stimulating specific targets deep in the brain, such as the nucleus accumbens for substance abuse disorders, at low and safe power levels commonly used for diagnostic imaging studies. However, a current concern in the use of TUS in human studies is the potential for an auditory effect to confound the results, especially in studies susceptible to the placebo effect or attention effects. The purpose of this proposed research is to enable more rigorous, and therefore successful, TUS studies for the treatment of SUDs and other neurological disorders.